Lead Exposure and Beta-Amyloid Transport by Brain Barriers

Ainctchuemaumlaytliooindocfabsceatad-eamleaydloinidg(tAoβn)eiunrbornaailnceexlltrdaacmelalguelairnptahreeentcihoylomgay aonf dAlfzluhiedimisetrh’sedkiesyeaesveent Project Summary/Abstract m(AaDin).tTaihneinbglotohde-hbormaineobsatrarsiiesro(fBAB?Bi)nabnrdaitnheexbtlroaocde-lCluSlFarbmarirliieeur .(PBbCBto)xpiclaityyaonnimbrpaoinrtbaanrtrrioerles in Bmms yBaesByttaeaabmnfofsdel,icsBwtmCthh.BiTce, hhfcaurcciosit,lmiictthaapeltrepocsrmeotnhictseeresaspslhtehhysyesipincoolbctehhraaeerismaninsibccieaas lratrrhnieaedatrceestvxiyoepsnntoetssumubareslelttywhtioaentePcnrrbeeAdgaβuasemlaasntaetdghAeePs?bltethiaroekannabsgsr, peauoilontrfitmbAaaaβnrtrdaeitleytrh e ltdehyainsdaihnmygpictoocthoaennstirinsa,cswrte-eeanshheadavnefocderemdsciagotnimoenpduotthferademetyoslmpoeiodcgiprfialcapqahiuyme(ssD.iICnnEba-oCimtTh)1bt,rowaqienuswa nailntlidfuysbtelhoteohdreevsaetla-sttsieem-losef. -Tbthroaeti-enasrtt rAoefPgfPiibomrniailclAebβdl odeovedeplofolsopiwtbs,rfbarlioonmoadmthvyeollobuirmda ipen,l?aasqncudaepBsiBlal aBsrwpy eevrlelmsaseseaWlbs iTtloi tmyi tibsceepf.aoWrreeenacwnhidyllmaafaltseoarscPahbarereaxscputoletsroui zfrePe btihneTsgh-i f t Aet(rRx?apAntoGrssapEuno)rs,reiptneionrtrshta,ebid.yBeo.Bm,sleBia-ptitonirmpel yareottedhtdeeeipwnBeCirnteBhdc.eePInnpbtt.AofAairmismphr3i oo2, ntwwe. ieWinl lw-e1foiwl(clLuiulRslsPefoo1nsc)yutanhsnceohdnrraooedltexrvpooarnnfeRcXsesA-dirGoagnEylsyaf lconuafdottirwLoeRnosPceAe-n1?ndicnperm(oXdeRduFica)ttsi ng abai mgfotgnaergreeiP(gnPbagbteteBexsncpah)onntsdoiuqrKeueseXtaa-ctrbodaluiyisfpfhfleleurtdheonerwetaisdtschsoeosinmcecisaemat(iunoKndnXotRbhimFeist)ewtto.eeTccehhhneenmsPieqbi susBtetrnuyqdautinoeadsncatowim-filyloyl rcleeoasailtidlaz-beti nilmPisbbehrwaPaibinnthcoaovnanedmcl beyclnoloontoircdadetpvi otensthss eai nlts athnedbbrlaoiondbvaersrsieerlss bpylaiynaveksetyigraotilneginthreegruellaattiinognsPhbi-pinbdeutwceedenAβPboleigxopmoseurrseaannddpplaeqrmueesaibnilbitryain cchhaannggeess ionf cberraeinbrbaalrvraiesrcsultaorApβerflmuxeeasbialnitdy pcoronvtridibeuctleuteosAasDtpoawthhoegtehneerscihsraonndicdPebveelxoppomseunret. and

Public health relevance
Narrative This study, by teaming together neurotoxicologist, molecular neurobiologist, medical imaging specialist and synchrotron physicist, will explore novel pathways of Pb?affected Aβ transport by brain barrier systems and will define the role of Pb exposure in AD pathogenesis. Results of this study will provide clues as to whether exposure to toxic Pb in the general population may contribute to the AD etiology. Potential discovery of Aβ transporters and metabolic regulatory mechanism in the brain barrier systems will help develop novel strategies for diagnosis, treatment and prevention of Alzheimer’s disease.